Injectable Hydrogels to Protect Transplanted Cells from Hypoxia

Project Summary
PAR-18-206: Injectable Hydrogels to Protect Transplanted Cells from Hypoxia
Cell transplantation by direct local injection is a promising strategy for many regenerative medicine therapies;
however, regardless of clinical indication, the therapeutic potential of this strategy has been drastically limited
by inefficient cell delivery and poor long-term survival of transplanted cells. We have recently designed an
injectable hydrogel that improves cell delivery by providing (1) mechanical shielding during the injection
process to prevent cell membrane rupture, (2) rapid gelation in vivo to localize cells at the intended delivery
site, and (3) cell-adhesive ligands that promote the spreading and migration of transplanted cells into the host
tissue. In a preclinical model of spinal cord injury (SCI), use of this hydrogel to transplant Schwann cells (SCs)
resulted in a significant increase in successful cell delivery, which correlated with improved therapeutic
outcomes. However, poor long-term survival of transplanted cells continues to be an unmet challenge due to
the hypoxic host environment. Therefore, we propose the development of two orthogonal biomaterial design
strategies (a biomechanical strategy in Aim 1 and a biochemical strategy in Aim 2) to create injectable
hydrogels that improve transplanted cell delivery and promote long-term survival in hypoxia. These materials,
named SHIELD (Shear-thinning Hydrogels for Injectable Encapsulation and Long-term Delivery) are fully
chemically defined to facilitate future FDA studies. As a proof of concept, SHIELD will be evaluated in a
preclinical model of SCI, where transplanted SC therapies are known to suffer from significant hypoxic cell
death. In Aim 1, we evaluate the hypothesis that matrix mechanics can alter the pro-survival secretome of
encapsulated cells, thereby creating soluble, autocrine signals that improve hypoxic survival. Cells will be
encapsulated in SHIELD materials with a range of stiffness, cultured under normoxic and hypoxic conditions
(5% and 1% O2, respectively), and assessed for viability, proliferation, secretion of neurotrophins and growth
factors, and markers of cell necrosis (cyclophilin A and fodrin breakdown product) and apoptosis (caspase-3
and TUNEL). As a parallel approach, in Aim 2, we evaluate the hypothesis that sustained, localized delivery of
pro-survival factors can be achieved through the design of stabilized, lipid-vesicle depots that physically
crosslink into our injectable hydrogel. The multi-lamellar lipid capsules are stabilized by inter-bilayer covalent
crosslinking, and the degree of crosslinking is used to tune the release rate. Thus, this modular design
strategy can be used to independently control the delivery kinetics of multiple pro-survival factors.
Encapsulated cells will be evaluated as in Aim 1. In Aim 3, we validate our in vitro findings in a preclinical rat
model of cervical, contusive SCI with SC transplantation. SC survival and distribution, native tissue response,
neuro-regeneration, and functional forelimb recovery will be assessed. In summary, because the success of
cell-based regenerative medicine therapies hinges on the survival of transplanted cells, technologies that
directly address cell death by hypoxia can significantly improve clinical outcomes.

Public health relevance
Project Narrative PAR-18-206: Injectable Hydrogels to Protect Transplanted Cells from Hypoxia Cell transplantation is a promising approach for many regenerative medicine therapies, however the therapeutic potential is significantly limited by poor survival of transplanted cells. This proposal aims to improve the clinical efficacy of cell transplantation for tissue regeneration through the design of an engineered, injectable hydrogel that provides biomechanical and biochemical signals that prevent cell death due to hypoxia, i.e. insufficient oxygen. As a proof of concept, this injectable material will be evaluated in a preclinical model of spinal cord injury, where transplanted Schwann cell therapies are known to suffer from significant hypoxic cell death.